Enrichment Program

PROJECT SUMMARY/ABSTRACT The enrichment program will comprise several activities, including a research symposium conducted at the time of the annual external advisory committee meeting, a research seminar series focused on the areas of research emphasis, and an annual update on dialysis and transplantation. In addition, research training is offered through the existing NIH training programs at UT Southwestern (T32, K12, and K30). Information on the research training program can be found later in the application. Each Biomedical Research Core offers hands-on training in research techniques. More information on this training can be found in the descriptions of the individual Cores.